GENES WITH SIGNIFICANT DEFICIT OF LOSS-OF-FUNCTION MUTATIONS IN LUNG TUMOR

ABSTRACT
Studies aimed at the identification of cancer-related genes usually focus on the genes with an excess of
somatic mutations. We hypothesized that genes with a lower-than-expected number of loss-of-function
(LOF) mutations are also cancer-related. Indeed, genes whose function is essential for tumor cell survival
and proliferation are expected to lack or have a deficit of LOF mutations since the loss of the function of an
essential gene will lead to death of the tumor cell. As a result, genes essential for tumor cell survival are
“prohibited” from having LOF somatic mutations and, therefore, can be identified through a deficit of LOF
mutations. We tested this idea in a pan-cancer analysis. We applied a multiple regression model to predict how
many LOF mutations one can expect in a given gene based on characteristics of the gene. Analysis of residuals
was used to identify negative outliers—i.e., genes with a lower-than-expected number of mutations in them.
After our pan-cancer analysis was published, the number of available mutations detected in tumors more than
doubled, making it possible to conduct a lung cancer-specific analysis which is expected to be more
powerful compared to the pan-cancer analysis. The cancer-essential genes identified in pan-cancer analysis
fall into two categories: (1) genes that are essential in general - common housekeeping genes, and (2) genes
that are nonessential in normal tissue but become essential after cells undergo malignant transformation. We
will focus on the genes from the second category because they are expected to be a better therapeutic target
than genes with housekeeping functions, as silencing the former is expected to have lower overall toxicity
compared to the silencing of housekeeping genes. We propose the following specific aims: Aim 1: To identify
genes with a significant deficit of loss-of-function mutations in lung tumors. Aim 2: To conduct pilot
functional studies of the genes with a significant deficit of LOF mutations. To summarize, we will use
existing somatic mutation data to identify genes in the human genome that are essential for survival of tumor
cells in lung cancer. We will conduct pilot functional studies to demonstrate that silencing of the genes with a
significant deficit of LOF mutations has antitumor effect.
1

Public health relevance
NARRATIVE Cancer develops and progresses because DNA mutations build up in normal cells, allowing them to grow uncontrollably. The mutation process is generally random, and how many mutations a gene can have depends in general on the gene’s characteristics, but some genes have the actual number of mutations that is significantly different from what can be expected from their characteristics, and such genes are highly likely to be cancer-related because the number of mutations cannot be explained otherwise. In this study we will focus on lung cancer and identify genes that lack or show a deficit of loss-of-function mutations. We expect that blocking these genes will kill lung cancer cells and stop cancer development.